Advancement of an Implantable Microphone

Project Summary: In a prior NIDCD-funded project, we developed a prototype implantable
microphone with the goal of enabling totally-implantable cochlear implants (TICI) that takes
advantage of the outer-ear acoustic benefits. This microphone, called the UMic, senses the
motion of the umbo (the distal tip of the manubrium) within the middle ear cavity. Due to its novel
design and fabrication, the UMic's performance rivals that of a conventional external cochlear
implant microphone in terms of sensitivity, bandwidth, linearity, dynamic range, signal-to-noise
ratio, and ability to reject and shield from electrical noise (such as cochlear implant signals). The
UMic was developed through iterations of analytical modeling, finite-element analysis, bench
testing and implanted testing in human cadaveric ears. Its exceptional performance derives from
its architecture: a triangular cantilever sensor comprised of two layers of piezoelectric polymer
polyvinylidene fluoride (PVDF) providing a differential output. This sensor, composed of fully
biocompatible materials, connects to a custom low-noise low-power differential amplifier.
This proposal addresses the refinements needed to make the UMic ready for human use.
The following four specific aims are planned. Aim-1 focuses on bench testing and refining the
UMic for long-term durability and performance. Aim-2 focuses on finalizing the fixation hardware
and tests the UMic in human cadaveric ears as refinements are made to the UMic system. Aim-
3 is a 2-month in vivo trial in sheep, to determine the effect of body noise on UMic performance
and evaluate durability in vivo. Aim-4 is motivated by the fact that cochlear implant users
experience sound signals differently than normal listeners. In Aim-4, cochlear implant users
evaluate signals that were recorded by the UMic when it was implanted in human cadaveric ears
and in live sheep. This allows UMic performance to be evaluated in Cl users without having to
implant the UMic in live human subjects. Aims-3 and Aim-4 will provide feedback to guide Aim-1
and Aim-2 to further advance UMic performance and durability. Given the advanced state of our
design and in preparation for the next translational steps, we have had meetings with the major
Cl companies with plans to meet periodically, and have also met with FDA representatives to be
followed with regular pre-submission meetings. With a functioning microphone in hand, and future
work comprising carefully laid out steps, at the end of this grant period we plan to have a
microphone ready for integration into a TICI which can then apply for FDA approval.

Public health relevance
Project Narrative We have developed a prototype implantable microphone as a component of a totally-implantable cochlear implant (TICI); its performance equals that of leading external microphones. A TICI can provide key advantages: it is invisible, it can be worn all the time during activities such as sleeping and sports, and its internal microphone will leverage the gain and directional cues provided by the external ear to improve hearing. Here we plan engineering activities and a large-animal study to ready the microphone for incorporation into a cochlear implant system, thereby removing the remaining primary obstacle facing TICI deployment.